Genetic and ecological determinants of coronavirus recombination

PROJECT SUMMARY:
Recombination is the process by which two viruses exchange part of their genetic material to produce a
‘daughter’ strain that is genetically distinct. For coronaviruses (CoVs), it is an important evolutionary mechanism
for generating genetic variation, but it is also an important driver of host switching. Most CoVs in humans are
thought to have originated in animals (in particular, bats) and have evidence of recombination in their evolutionary
history. Despite the relevance to public health, the mechanism, drivers, and limitations to recombination remain
unclear. Using a combination of laboratory experiments, comparative genomics, and mathematical modeling, we
will test the hypothesis that the probability of recombination between two CoVs is a function of genetic distance,
and that this probability is further modified by ecological or evolutionary effects. In other words, the likelihood of
recombination decreases as the genetic distance between the parental strains increases (presumably because
of genetic or structural incompatibilities), but is also impacted by ecological processes such as the chance that
two CoVs will actually co-occur or evolutionary selection pressure. We will test three aims: In Aim 1, we will
employ laboratory studies and co-infect human and bat cell lines with pairs of CoVs over a phylogenetic gradient.
This will test whether the probability of recombination is related to genetic distance between the parents, and will
also show whether recombination occurs randomly throughout the genome or in particular ‘hot-spots’. In Aim 2,
we will evaluate naturally occurring CoVs using genomes available in public databases or from our own previous
work. Presumably, naturally occurring recombinants will be the result of any genetic limitations (e.g., genetic
distance), plus any ecological or evolutionary modifiers (e.g., natural selection). Thus, by comparing the
laboratory (Aim 1) and observational (Aim 2) studies, we can begin to identify patterns that would remain unclear
with experimental data alone, allowing us to disentangle the contributions of both genetic and ecological factors
to the probability that any two viruses will recombine. This understanding can then be used to improve predictions
of both the potential and probability of CoV recombination. Finally, we will extrapolate these effects to generate
a spatial model that estimates of the risk of recombinant CoVs arising in different parts of the world (Aim 3). By
integrating our unique global CoV surveillance data (>31,000 animals from >25 countries surveyed for CoVs) we
will produce a risk map predicting regions of the world where recombination is most likely.

Public health relevance
PROJECT NARRATIVE: Recombination is an important driver of genetic diversity in coronaviruses (CoVs) and is thought to be a primary mechanism driving host-switching. The goal of this study is to examine laboratory and natural recombination events to identify patterns or trends that can be used to infer genetic or ecological drivers of recombination. This will advance our understanding of both the potential and probability of CoV recombination.